Multi-morbidity in Uganda Research Capacity Initiative (MURCI) at Mbarara University of Science and Technology

1.0 Abstract
Chronic, non-communicable diseases (NCDs) now account for over half of morbidity and reductions in quality
of life, in resource-limited settings. Of particular importance is the growing epidemic of multi-morbidity, or the
accumulation of chronic conditions, including combinations of both non-communicable (e.g. hypertension,
diabetes, COPD, traumatic accidents, and cancer) and communicable diseases (e.g. HIV, prior lung disease
from pneumonia) on functioning, well-being and quality of life. Despite the growing appreciation of overlapping
conditions and their cumulative effect on health outcomes, the majority of disease treatment programs, donor
funding mechanisms, and research infrastructures focus on infectious diseases, and such programs remain
largely siloed. This separation of efforts results in three critical short-comings to the research infrastructure in
many low-income settings: 1) a poor understanding and limited attention paid to the interactive effects
between, and management of, comorbid conditions; 2) lack of attention to region-specific risk factors for multi-
morbidity that are likely to differ from high-resource settings (e.g. social determinants of health, occupational
exposures, air pollution); and 3) a near total absence of the requisite laboratory infrastructure for cross-cutting
multidisciplinary clinical research to support holistic care for those with multi-morbid conditions. To respond to
these gaps in research infrastructure in Uganda, we will conduct the following specific aims:
Aim 1: Develop junior faculty expertise in Uganda on multi-morbidity. We will focus training on a
holistic understanding of human health, and an understanding of how accumulation of chronic
conditions impacts functioning and quality of life in this setting.
Aim 2: Train junior faculty to measure determinants and consequences of the regional social
and environmental risk factors for multi-morbidity. Key focus areas will include social-behavioral
and environmental determinants of health.
Aim 3: Develop laboratory capacity to support clinical research on multi-morbidity. We will
leverage an established Memorandum of Understanding between the Massachusetts General Hospital
(MGH) and the Mbarara University of Science and Technology (MUST) Clinical Research Laboratory to
support capacity building, quality assurance, and a trans-disciplinary clinical laboratory program to
focus on multi-morbidity diagnostics and regionally appropriate risk factor testing.
In this D43 research training program, we will leverage a 15-year partnership between MUST and MGH, to
provide sustained mentorship and protected research time to 12 promising post-doctoral and junior faculty
members at MUST and establish a Ugandan regional center of excellence in multi-morbidity research.

Public health relevance
2.0 Project narrative Chronic, non-communicable diseases (NCDs) now account for over half of morbidity and quality of life reductions in resource-limited settings. Of particular importance is the growing epidemic of multi-morbidity, or the accumulation of chronic conditions, including combinations of both non-communicable and communicable conditions on well-being and quality of life. However, the majority of disease treatment programs, donor funding mechanisms and research infrastructure focuses on infectious diseases, and most such programs are siloed. This D43 training program application will directly respond to PAR-18-901 (“Chronic, Non- Communicable Diseases and Disorders Across the Lifespan: Fogarty International Research Training Award”) by strengthening the capacity of Ugandan junior investigators to pursue research careers on NCDs and multi- morbidity through a proven co-mentoring model of sustained training. Our over-arching goal is to build a foundation of independent junior investigators upon which to build a regional center of excellence in the study of multi-morbidity in Uganda.